The role of prenatal nutrition in placental gene regulation and spontaneous preterm birth

PROJECT ABSTRACT
A fundamental question bridging the fields of nutrition and developmental biology is identifying nutritional
requirements during pregnancy that support optimal fetal development. The placenta is the sole source of
nutrients for the fetus and prenatal nutrition influences placental function. While prenatal nutrition plays a vital
role in programming maternal and infant health outcomes, the roles of essential nutrients in the placenta are
poorly understood. Moreover, nutrition recommendations for pregnancy were set without regard for preventing
adverse pregnancy outcomes. The proposed research seeks to address these knowledge gaps to understand
how nutrient–gene interactions influence placental biology and pregnancy outcomes. I propose to build a
genome-scale nutrient regulatory network (NRN) of the human placenta and leverage it to identify real-world
nutrient mixtures associated with an important adverse pregnancy outcome, spontaneous preterm birth (sPTB).
My research plan builds on my background in developmental nutrition and ‘omics analysis. During the K99
mentored phase, I will engage in didactic training in placental biology, network analysis, and molecular
epidemiology. I have recruited a multidisciplinary mentorship and advisory team with a strong record of
collaboration, who will support my success in executing the proposed aims. I will establish and computationally
validate a placental NRN using existing nutrient intake data collected during mid-pregnancy and gene expression
in placentas collected at birth in a large, well-characterized pregnancy cohort (Aim 1). In the R00 independent
phase, I will harness training in placental biology, network analysis, and molecular epidemiology to investigate
nutritional regulation in sPTB. I will use the NRN and our published transcriptomic signature of sPTB to identify
candidate nutrients and real-world nutrient mixtures associated with sPTB to validate the candidate nutrients in
a nationwide consortium of pregnancy cohorts (Aim 2). This aim will provide specific insight into the most
important nutrients as potential targets in interventions to prevent sPTB. In parallel, I will use causal inference
methods to estimate effects in silico of public health interventions using widely available, over-the-counter
prenatal vitamin/mineral supplements (PV) (Aim 3). I will identify a real-world nutrient mixture associated with
low sPTB risk and use reported nutrient intakes to estimate an intervention that will optimally shift nutrient intakes
and likewise evaluate its effects as a public health intervention. This aim will estimate the effects of a nationwide
PV intervention compared to empirical results and provide direct translational value. Successful completion of
this proposal will represent a significant step towards understanding how prenatal nutrition influences placental
function and will identify real-world nutrient mixtures that contribute to adverse outcomes like sPTB. Finally, this
K99/R00 will provide mentorship and training needed to establish and lead an independent lab investigating
nutritional regulation of development using network biology, molecular epidemiology, and ‘omics approaches.

Public health relevance
PROJECT NARRATIVE The proposed research applies network approaches to understand how prenatal nutrition influences placental biology and in turn leads to spontaneous preterm birth. This project will shed light on critical yet poorly understood roles of micronutrients in development and prioritize placental biological pathways that can be targeted through nutritional intervention to improve maternal and infant health outcomes.